Develop novel iNOS/NO inhibitors for mitigating inflammatory cell death, ARDS, and MODS

Project Summary
Many causes can trigger excessive production of inflammatory cytokines (i.e., cytokine storm). Elevated
circulating cytokines induce extensive cell death (i.e., inflammatory cell death) that causes severe organ
injuries, eventually leading to acute respiratory distress syndrome (ARDS) and multi-organ dysfunction
(MODS). Patients with ARDS and MODS have extremely high mortality (~46%). There is an unmet clinical
need for novel therapeutics capable of inhibiting inflammatory cell death to mitigate ARDS and MODS. Recent
studies find that the excessive expression of inducible Nitric Oxide Synthase (iNOS) and over-production of
nitric oxide (NO) play a critical role in inflammatory cell death. Therefore, inhibiting iNOS/NO represents a
promising therapeutic approach. Hydrogen sulfide (H2S), a gaseous signaling molecule in our body, is known
for its capability to inhibit iNOS and quench NO. However, due to its gaseous nature, its therapeutic application
is limited by the challenge of administering a precise dose into the target cells sustainably. Preliminary studies
developed five polymeric micelles containing H2S donating-anethole dithiolethione (ADT) groups to overcome
the problem. The micelles enter cells via endocytosis and release H2S upon oxidation by reactive oxygens
species (ROS) inside cells. The release rate can be controlled by changing the polymer design. The micelles
have no significant cytotoxicity. In a proof-of-concept study, the micelles effectively inhibited cytokine-induced
cell death. In short, the data show that the micelles are promising drug candidates. This project proposes
systematically evaluating their therapeutic potential using vitro and mouse models, with the goal of gathering
robust evidence to support their advancement into full drug development. The hypothesis is that the micelles
can effectively mitigate iNOS/NO, inflammatory cell death, ARDS, and MODS. Aim 1 will test the hypothesis
that micelles can mitigate iNOS/NO activity and inflammatory cell death in vitro. Aim 2 will test the hypothesis
that micelles can mitigate cytokine storm, inflammatory cell death, organ injury, and mortality in mouse models.
This project will collect essential efficacy/potency data, identify the most promising candidates, and provide
valuable insights into polymer structure-property relationships to optimize these candidates further. The work is
significant, as it has the potential to lead to novel therapeutics for managing ARDS and MODS, conditions
responsible for ~11 million deaths annually. In terms of innovation, this is the first to investigate H₂S as an
iNOS/NO inhibitor to reduce inflammatory cell death, cytokine storms, ARDS, and MODS. The micelle design
is also highly innovative, enabling sustained, targeted, and ROS-responsive intracellular delivery of H₂S - a
combination of features currently unmatched by any existing technology.

Public health relevance
Project Narrative Many causes can trigger excessive production of inflammatory cytokines. Elevated circulating cytokines induce extensive cell death (i.e., inflammatory cell death) that causes severe organ injuries, eventually leading to acute respiratory distress syndrome (ARDS) and multi-organ dysfunction (MODS). This project aims to develop polymeric micelles that can release H2S for mitigating inflammatory cell death, ARDS and MODS.